Protection of hematopoietic stem progenitor cells from endogenous DNA damage

Project Summary
Maintaining genome integrity is critical for hematopoietic stem cells (HSCs) as they self-renew and differentiate
into all blood cells throughout one’s life with enormous regenerative capacity. HSCs depend on the Fanconi
anemia DNA repair pathway that removes DNA interstrand crosslinks. Endogenous reactive aldehydes are
important sources of DNA damage that patients with Fanconi anemia are vulnerable to. Unfortunately, we do not
know all the types and extent of reactive aldehydes that are important in human diseases. Moreover, there are
no FDA-approved therapies that reduce aldehydic load and prevent DNA damage for patients with Fanconi
anemia. In this R00 proposal, we propose to dissect the role of all the ALDH and ADH isoenzymes in human
HSCs using a xenotransplant model and single-cell CRISPR screen. We also aim to uncover novel disease
modifiers that can enhance aldehyde detoxification capacity through the CRISPR activation screen. Finally, we
aim to prevent endogenous aldehyde-induced DNA damage in Fanconi anemia by activating detoxifying
enzymes or extracellular vesicle-mediated delivery of functional enzymes. Knowledge gained through our studies
will establish novel therapeutic strategies useful for preventing bone marrow failure and malignancies in Fanconi
anemia.

Public health relevance
Project Narrative Fanconi anemia is one of the most common inherited causes of low blood counts. Reactive aldehydes cause DNA damage that is detrimental to patients with Fanconi anemia due to their DNA repair defects. Our study aims to enhance aldehyde detoxification capacity to prevent DNA damage and disease progression in Fanconi anemia.